CD74 and Wound Healing

Project Summary
The mucosal epithelial barrier becomes disrupted in many conditions such as surgical procedures, trauma,
inflammatory bowel diseases, ischemia, infections, radiation, and chemotherapy. Epithelial cell regeneration is
essential for mucosal wound closure and healing.
Our overall goal is to understand the mechanisms that lead to effective mucosal wound closure. This proposal
builds on our recent discovery of an intestinal mucosal wound repair mechanism involving CD74 signaling.
CD74 is the receptor for the MIF cytokine.
The proposal aims to address significant questions that remain unanswered in the CD74 signaling pathway
and wound repair, and are worth exploring. Our research is motivated by three key questions based on our
published and preliminary data: What is the mechanism that drives epithelial CD74 receptor expression (Aim
1)? Can we safely and effectively stimulate CD74 (Aim 2)? What are the functional consequences of human
genetic variation on CD74 activity (Aim 3)?
Knowledge gained from these studies will significantly advance our mechanistic understanding of CD74
biology and mucosal wound repair, and may lead to new therapeutic strategies for promoting mucosal wound
healing.

Public health relevance
Narrative There is an urgent need to improve our understanding of the mechanisms underlying effective mucosal wound closure and develop new therapeutic strategies for mucosal wound healing. This proposal will advance our understanding of the role of the CD74 signaling pathway in intestinal epithelial repair and mucosal healing. The work is relevant to public health as the information gained may ultimately lead to effective treatments to heal the mucosa.